Improving Induced Pluripotent Stem Cell-Derived Endothelial Cells as Therapy for Peripheral Arterial Disease

Veterans experience peripheral arterial disease (PAD) onset at an earlier age than their non-Veteran
counterparts and are at increased risk of experiencing adverse outcomes from this disease. Advanced PAD is a
significant cause of morbidity, including major amputation. While endovascular and surgical treatment options
have advanced, often patients are limited to palliation consisting of pain control and major amputation, both of
which lead to significant morbidity and disability. There remains a great need for improved therapeutic modalities
to prevent limb loss.
Advanced PAD is a disease of aging, driven by age-related mitochondrial dysfunction, or mitochondriopathy,
and resulting loss of innate vascular regenerative function. For patients facing major amputation, vascular
regenerative therapies from combined pharmacologic treatments and exogenous stem cells present a novel
avenue for therapy to improve function and prevent major amputation. Prior work demonstrated the potency of
induced pluripotent stem cell-derived endothelial cells (iPSC-ECs) in accelerating vascular regeneration in
murine ischemic hindlimbs. Our prior work demonstrated improved function of iPSC-ECs with Rg2-mediated
stimulation of mitophagy. The renewability and scalability of iPSC-based technology provides an advantageous
platform for cell therapy to treat ischemic PAD limbs.
In Aim 1, we hypothesize that Rg2 treatment of aged murine aortic ECs will act through the HIF-1α/VEGF-A
pathway to similarly reverse native EC mitochondriopathy and support sprouting angiogenesis. We will use aged
(22-25 month old) and young (5 month old) MtKeima mice, expressing the pH-sensitive dual-excitation
fluorescent protein Keima, to track mitochondrial recycling in lysosomes in isolated cells and tissues. We will use
harvested ECs from these mice to explore the impact of Rg2 on angiogenesis in vitro, and we will use the
hindlimb ischemia (HLI) model on live aged mice to explore the impact of Rg2 on vascular regeneration in vivo.
This aim will evaluate the effect of stimulating mitophagy to reverse mitochondriopathy and to restore
regenerative capacity in native ECs.
In Aim 2, we hypothesize that iPSC-EC survival in an ischemic foot will require a primed implantation bed,
as well as embedded exogenous support, to achieve functional angiogenesis. To test the minimum necessary
support, we will utilize an in vitro model of angiogenic sprouting with varying levels of nutritional support to assess
iPSC-EC performance. We will then use the HLI technique in aged mtKeima mice and embed optimized iPSC-
ECs in Rg2-primed and unprimed limbs. This aim will evaluate the combined requirements of pharmacologic and
cellular therapy to treat advanced limb ischemia in a murine model of age-related ischemia.
This CDA2 will provide me with the training and experience to apply advanced in vitro and murine models to
optimize regenerative approaches for human clinical trials, to ultimately address this critically unmet clinical need
among Veterans. This training will equip me to achieve VA Merit funding and further my career as a VA vascular
surgeon-scientist.

Public health relevance
Peripheral arterial disease (PAD) is prevalent among Veterans and remains a source of significant morbidity and disability. Veterans experience PAD onset at an earlier age than their non-Veteran counterparts and are at increased risk of experiencing adverse outcomes from this disease. Lack of regenerative function in Veterans with PAD leads to disability and can result in major amputation. Novel pharmacologic and cellular therapies provide hope for patients in need of regenerative therapies. Induced pluripotent stem cell-derived endothelial cells (iPSC-ECs) have demonstrated potential to restore perfusion in ischemic murine hindlimbs, but have not been tested with age-related ischemia, which is the cause of PAD. This project aims to utilize a novel aged mtKeima hindlimb ischemia model to (1) optimize the mitochondriopathy and regenerative capacity of the recipient ischemic limb; and (2) quantify the minimum necessary support for exogenous iPSC-EC therapy to achieve functional and meaningful reperfusion in the challenging scenario of age-related ischemia.